The Duke FUNCTION Center: Pioneering the comprehensive identification of combinatorial noncoding causes of disease

ABSTRACT: Noncoding genetic variation that alters gene regulatory element activity has major impacts on
health, disease, and evolution. Because measuring regulatory element activity has long been a major challenge,
the mechanisms underlying thousands of genetic associations with disease remain unknown. Recent advances
in high-throughput technologies have disruptively advanced the ability to measure the activity of individual
regulatory elements, and the first population- and genome-scale uses of those methods are now underway.
However, regulatory elements do not act alone. They interact with promoters, other regulatory elements, and the
surrounding chromatin, all in ways that are complex and difficult to predict. Though there are now a plethora of
technologies to measure the activity of individual regulatory elements, the ability to recapitulate the effects of
combinations of regulatory elements is woefully inadequate and severely hinders efforts to establish the gene
regulatory contributions to traits and diseases. The goal of the Duke FUNCTION Center of Excellence in
Genomic Science is to make the study of the combinatorial activity of regulatory elements routine. Aim
1 is to develop a suite of new technologies to measure the combinatorial effects of regulatory elements in their
endogenous genomic contexts. Those technologies will leverage very recent discoveries of CRISPR enzymes
other than Cas9 that greatly expand the ability to manipulate the human genome. Aim 2 is to develop the matched
computational, statistical, and evolutionary models needed to interpret and predict the measured effects of
combinations of regulatory variants on human traits and diseases. Aim 3 is to demonstrate the broad applicability
of the technologies developed through case studies of human diseases with prevalence ranging from common
to ultra rare. Example case studies will include studies of schizophrenia, rare recessive disorders, and
undiagnosed genetic disorders. We will also use a nationwide request for applications to identify Pilot Projects
that will expand applications to other disease areas. Aim 4 is to create an electronic platform for distributing
results from functional studies of the noncoding genome to the broad research community. The platform will
integrate our results with those from studies in other labs and consortia, such as ENCODE; and will enable
researchers with diverse expertise to benefit from the Center. Finally, our Education and Outreach Aim is to
expand genomics capacity locally and nationally, and with a particular emphasis on increasing use of our new
technologies for translational research. The expected outcome of this project will be a paradigm shift in human
genetic and genomics in which it will become possible to finally understand the full regulatory complexity that
controls the expression of human genes. We anticipate that ability will be particularly powerful for translating
genetic associations into disease mechanisms, thus creating a windfall of new knowledge about which genes
contribute most to disease, and how to manipulate those genes for therapeutic benefit. Long term, we envision
this work being critical to realizing the full potential of whole genome sequencing to detect causes of disease.